Auditory circuit organization following gene therapy for congenital deafness

PROJECT SUMMARY
This project seeks to understand the critical role of otoferlin in auditory circuit development and how gene
therapy can be optimized to restore hearing in patients with congenital deafness caused by otoferlin variants.
Otoferlin is a key calcium sensor that facilitates synaptic vesicle fusion and neurotransmitter release at inner hair
cell (IHC) synapses, essential for transmitting sound information to the auditory nerve. In individuals that harbor
certain otoferlin variants, abnormal function of otoferlin leads to profound hearing loss. Recent clinical trials have
successfully restored hearing by delivering functional otoferlin via gene therapy, but there remain unanswered
questions about how otoferlin shapes early auditory circuit development and how its restoration influences
auditory system organization and plasticity, especially after prolonged deafness. This project aims to examine
how otoferlin knockout (Otof KO) mice respond to gene therapy by exploring spontaneous activity patterns,
auditory cortex organization, and potential methods to enhance neural plasticity.
In this proposal, we will investigate how spontaneous neural activity patterns are disrupted in Otof KO
mice, as spontaneous activity is crucial for the development and refinement of sensory circuits. Using widefield
imaging techniques, we will examine spontaneous activity in the cochlea, inferior colliculus (IC), and auditory
cortex (AC) of Otof KO mice to determine how the absence of otoferlin affects neural signaling before hearing
begins. We will also explore how the timing of otoferlin gene therapy influences auditory cortex organization and
plasticity. Otof KO mice will receive gene therapy at different developmental stages (P1, P7, and P21), and their
cortical responses to sound will be monitored over time. We anticipate that earlier intervention will lead to cortical
responses that are indistinguishable from controls, while late intervention will result in loss of tonotopic precision
and limited cortical reorganization. To extend these studies, we will investigate whether visual deprivation can
enhance plasticity following otoferlin gene therapy. Sensory deprivation, such as placing the treated mice in
complete darkness, has been shown to enhance cortical plasticity in the auditory system, suggesting that it could
help the cortex adapt more effectively to restored hearing. By examining changes in auditory cortical activity in
Otof KO mice following gene therapy and visual deprivation, we hope to identify strategies that could boost
plasticity and improve auditory rehabilitation, particularly in adults with congenital deafness who display limited
recovery of linguistic abilities when hearing sensation is restored. Together, this research will provide valuable
insights into how otoferlin contributes to auditory development, inform optimal timing for gene therapy
interventions, and explore novel approaches to enhance plasticity, ultimately improving outcomes for patients
undergoing hearing restoration.

Public health relevance
PROJECT NARRATIVE Otoferlin is critical for proper signaling from sensory hair cells to the auditory nerve fibers, however, it is unclear how disruption in otoferlin function influences auditory circuit development or how sudden hearing restoration following gene therapy will sculpt and refine existing cortical circuits. Using otoferlin knockout mice and calcium imaging techniques, we seek to explore how peripherally generated spontaneous activity is altered before hearing begins, how auditory cortex organization changes following prolonged deafness and after gene therapy, and if visual deprivation, a known plasticity-increasing regimen, can facilitate the reorganization of the auditory cortex following gene therapy in adult mice.